Sharing canonical human stroke data

Despite significant progress in stroke prevention and its acute treatment, stroke remains the third leading cause of death and the leading cause of adult morbidity worldwide. Fundamental advances in stroke will require collecting and pooling advanced phenotype (e.g., neuroimaging) and genetic data from multiple centers. Description of and access to the data will also require a common stroke-specific lexicon. We have therefore initiated efforts to promote sharing and distribution of imaging and genetic data, www.strokedatabase.org and www.strokegenetics.org, and a lexicographic categorization tool, ccs.martinos.org. Using these portals, data and tools are available to individual research groups. We seek to expand our ability to distribute data and tools by linking our efforts to the infrastructure provided by the Biomedical Informatics Research Network (BIRN). We will initially distribute data using the BIRN service, Extensible Neuroimaging Archive Toolkit (XNAT) Central, to insure our data compatibility with the BIRN Data Repository (BDR). We will then work with BIRN domain experts to begin to incorporate stroke data specific terms into the BIRN ontology to ensure successful port and distribution of our data using the BDR. Linking our existing portals with BIRN resources has the potential to greatly facilitate data sharing which will benefit the understanding of stroke and speed discovery of new therapeutic interventions.

Public health relevance
Stroke remains the third leading cause of death and the leading cause of adult morbidity in the world despite marked progress in its prevention and acute treatment. Key to improving understanding stroke pathogenesis that can lead ultimately to greater treatment options is pooling of stroke patient data and computational resources. We propose sharing our human stroke neuroimaging, clinical and genetic information as well as data analysis programs using the Biomedical Informatics Research Network infrastructure.